Transcription Through Nucleosomes in Vitro by E. coli RN

This project addresses the intriguing question of how eukaryotic RNA polymerases transcribe through chromatin. The project involves development of the minimal in vitro system for transcription through nucleosome by Pol II, and Pol III from S. cerevisiae. RNAP from E. coli, which behaves very similarly to the eukaryotic enzyme in nucleosomal transcription, is used in this project as an easy-handled prototype of Pol II (Kireeva et al., Molecular Cell, 2002).